IMMUNE MODULATION OF THE FETUS BY INTRA-AMNIOTIC IL-1

This subproject is one of many research subprojects utilizing the resources provided by a Center grant funded by NIH/NCRR. Primary support for the subproject and the subproject's principal investigator may have been provided by other sources, including other NIH sources. The Total Cost listed for the subproject likely represents the estimated amount of Center infrastructure utilized by the subproject, not direct funding provided by the NCRR grant to the subproject or subproject staff. Bronchopulmonary dysplasia (BPD) is the most common complication in very low birth weight (VLBW) newborns, and is diagnosed in about 15,000 infants in the U.S. BPD results in lifelong pulmonary disabilities and is associated with neurodevelopmental deficits. The IL-1/IL-17 axis has been shown to be a critical mechanism involved in the development of lung inflammation in these VLWB preterm babies.